Pioneering assays for spatially-resolved single-cell multiomics

Project Summary:
Disease often stems from cellular dysfunction, and single-cell transcriptomics has been instrumental in unveiling
the incredible diversity of cell types and advancing our understanding of their roles in health and disease. Yet,
cells do not operate in isolation. Recognizing the spatial relationships between cells, in addition to their individual
molecular profiles, offers crucial insights into cellular organization and communication, revealing the intricate
networks that underlie both normal development and disease pathways. These intercellular dialogues serve as
the foundation for most disease progressions and can be targeted to gain insights and potentially reverse the
disease course.
At Survey Genomics, we have developed Cytope-drop, an innovative approach for spatial barcoding of individual
cells that enables high-throughput spatially-resolved multiomics (transcriptome, cell surface proteins, etc.).
Cytope-drop integrates with existing droplet-based single-cell sequencing workflows, delivers gold-standard
single-cell multiomic data, and does not require additional capital equipment. In this resubmission, we propose
to further increase the spatial resolution of Cytope-drop to 50-um, scale manufacturing capabilities, and achieve
FFPE sample compatibility. Through these activities, Survey Genomics aims to bring to the market a product
that enables researchers to perform single cell analysis while obtaining spatial context simultaneously.
Cytope-drop compares favorably to a number of approaches that have emerged for spatial transcriptomics.
Current sequencing and imaging based spatial transcriptomic approaches focus on localizing transcripts,
whereas Cytope-drop focuses on localizing cells and obtains mRNA abundances, protein abundances, and cell
locations for the same cells in a single assay. Compared to existing commercially available spatial
transcriptomics methods, our approach stands out in several key ways: 1) no capital equipment costs, 2) delivers
true single-cell molecular profiles, 3) multimodal data (including RNA expression, protein expression, chromatin
accessibility, etc.), 4) high-throughput capacity, and 5) compatibility with current single-cell processing
techniques.
In summary, our proposal aims to develop and commercialize the only platform to-date that delivers mRNA
abundances, protein abundances, and cell locations for the same cells in a single assay. Survey
Genomics is uniquely poised to deliver on the proposed aims with our world-class team extensively
experienced in single-cell and spatial genomics, established manufacturing and financing partners, and
strong IP position. True single-cell data with spatial context, low cost, and high throughput position Cytope-
drop as a compelling approach to deliver new insights into the role of cellular organization and communication
in solid cancers, autoimmunity, neurodegeneration, fibrosis, and more.

Public health relevance
Project Narrative Survey Genomics is revolutionizing tissue biology with Cytope-drop, a groundbreaking assay platform for spatially-resolved, single-cell multiomic profiling of tissue sections. This innovative technology is compatible with existing droplet-based sequencing platforms and offers a low-cost, user-friendly, and high-throughput platform to understand how cells organize and communicate. By elucidating cellular interactions in healthy and diseased tissues, including tumors, Cytope-drop promises to advance disease understanding, patient stratification, and biomarker discovery for monitoring disease progression and therapeutic response.